Enhancing Multisystemic Therapy (MST) Effectiveness: A Novel Approach Using MY-SCOPE and Machine Learning for Within Session Communication Analysis

Project Summary/Abstract
Adolescents exhibiting serious externalizing symptomatology, represent large and underserved populations
that are at high risk of presenting significant deleterious outcomes and long-term costs for themselves, their
families, communities, and society. Evidence for the effectiveness of family-based treatments for adolescents
presenting such serious clinical problems (i.e., substance abuse, serious and chronic delinquency) has led to
efforts to disseminate these and other evidence-based treatments (EBTs) into real-world practice settings.
While model-specific training, supervision, and fidelity monitoring has been a major feature of current
strategies to transport and implement a variety of EBTs for children and adolescents into community practice
settings, where most children are treated, even the most extensively studied and effective EBTs are not
universally effective with every family. One of the most widely studied and disseminated EBTs targeting
adolescents with serious clinical problems, Multisystemic Therapy (MST), has shown large effect sizes in
efficacy studies conducted in controlled settings, but like other EBTs, its efficacy in real-world practice settings
remains far from optimal, especially for underserved, multi-problem and multi-stressed families. The modest
success of EBTs in real-world settings can, in part, be attributed to the emphasis placed on therapists
achieving treatment fidelity during implementation rather than providing guidance on how to manage the
complex, nuanced interpersonal communication processes that inevitably occur during the delivery of EBTs. A
largely ignored area of research in implementation science has been the examination of therapists’ skills and
competencies in managing interpersonal communication processes at the heart and soul of behavior change.
Recent advancements in multivariate time-series analyses and machine learning allow scientists to make
significant advancements in the study of psychotherapy processes by examining therapist-client
communication sequences that are differentially associated with class membership in treatment response
trajectories. Using audio session recordings, taken from a secondary data source, a completed NIMH-funded
longitudinal effectiveness study of MST, we will use supervised and unsupervised machine learning
techniques, coupled with a validated observational behavioral coding scheme (Minority Youth Sequential Code
for Observing Process Exchanges; MY-SCOPE) as labels to train algorithms, to recognize communication
patterns associated with class membership in treatment response trajectories. Identifying communication
sequences using MY-SCOPE and machine learning, the proposed R21 study seeks to provide actionable
recommendations for refining MST training materials and advance understanding of therapist-caregiver-youth
communication sequences associated with MST outcome.

Public health relevance
PROJECT NARRATIVE This study will help determine which therapist communication skills facilitate the empathetic, collaborative, and engaging atmosphere characteristic of Multisystemic Therapy sessions. It will also promote understanding of which therapist communication skills help increase caregiver motivation to change and which therapist communication skills are related to youth reducing their problem behaviors below clinical levels. The findings from this study will provide important information about core content and interpersonal process skills that are important for Multisystemic Therapy to be most helpful.